CHRONIC KIDNEY DISEASE IN CHILDREN STUDY (CKID)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to determine the risk factors for decline in kidney function and determine how decline in kidney function affects neurocognitive behavior.